POTENCY LEVELS IN STANDARDIZED ALLERGENIC EXTRACTS

Lot-by-Lot release continues for extracts containing Antigen E (Amb a 1) and Cat allergen I (Fel d I). Data bases have also been created for each mite species, as each lot of standardized mite is now released by CBER. The efforts to standardize cat extract have added valuable information to this database. Venoms have also been monitored for product consistency.